Role of an arousal circuit in respiration and opioid-induced respiratory depression

PROJECT SUMMARY
This K99/R00 Pathway to Independence Award is designed to allow the candidate to achieve her long-term
goal to establish an independent research career focused on how arousal circuits in the brain control
breathing, and how these neural mechanisms are influenced by opioids. This proposal has been tailored to
supplement the candidate’s background in neuroscience and respiratory neurophysiology with additional
knowledge and technical skills to study respiratory control circuits in vivo and ex vivo, and will make her ideally
suited to succeed on her career path. The primary cause of death from an opioid overdose is respiratory
depression. The sedative effect of opioids further impairs respiratory drive through largely unexplored
mechanisms. Although overdoses are routinely treated with the opioid antagonist, naloxone, naloxone
reverses all opioid effects, causing pain and withdrawal. Our current understanding of opioid effects on the
respiratory circuitry has not revealed an ideal therapeutic target to minimize respiratory depression without
serious side effects. Therefore, it is essential to identify new strategies to alleviate respiratory depression and
stimulate breathing. This proposal seeks to uncover important new insights whereby the locus coeruleus (LC),
a brain structure widely known for its contributions to arousal, influences the Kӧlliker-Fuse (KF), a key
respiratory region, which is highly sensitive to opioids and critical for opioid-induced respiratory depression.
Preliminary data spanning cell-type specific neural tracing, ex vivo brain slice recordings, and in vivo
optogenetics and fiber photometry, support a role for LC input to the KF in respiration, which has not been
previously appreciated. Based on preliminary data, the overall hypothesis is that the LCKF circuit is a critical
modulator of respiratory function, particularly during opioid-induced respiratory depression. The candidate’s
prior training in brain slice recordings, in vivo electrophysiology in awake animals, and intersectional viral-
genetic methods provides a solid foundation for the state-of-the-art ex vivo and in vivo optogenetics and fiber
photometry techniques in the proposal. This multi-level approach will allow the candidate to test the hypothesis
that KF neurons receive opioid-sensitive, monosynaptic excitatory input from LC neurons (Aim 1), that KF
projecting LC neuron activity is coupled with respiration in vivo (Aim 2), and the LCKF circuit plays a key
role in respiration and opioid-induced respiratory depression (Aim 3). Together, the aims of this proposal will
yield novel information regarding the brain’s control of respiration and will also provide strong conceptual and
methodological training, enabling development of an impactful and successful independent research program.
Strong mentorship by Drs. Erica Levitt and David Fuller, as well as a Mentoring Committee comprised of
established professors, who are experts in the proposed techniques and have extensive mentoring
experience, will help the candidate achieve the research and career development goals of this proposal.

Public health relevance
PROJECT NARRATIVE The primary cause of death from an opioid overdose is respiratory depression. Opioid-induced sedation further impairs respiration through largely unexplored mechanisms. The outcomes of this project will provide fundamental insights into the neurobiological control of respiration, the influence of opioids, and will possibly identify new strategies to alleviate respiratory depression and stimulate breathing.